Evaluating a mobile health tool to improve management of pediatric acute respiratory illness in Uganda

Candidate: Dr. Ellington is a pediatric pulmonologist at the University of Washington (UW) and K12
UW-Implementation Science Training Grant recipient (NHLBI). She completed a Master of Science in
Epidemiology at the UW School of Public Health and has a long-term track record of successful global
health research. Dr. Ellington’s long-term goal is to become an independent physician-investigator
working to improve health outcomes of pediatric respiratory conditions in resource-constrained settings.
Her career development plan includes coursework, experiential learning, and mentorship to achieve
training goals in 1) complex qualitative and mixed methods, 2) pragmatic clinical trials and quasi-
experimental studies, 3) advanced implementation science, and 4) global health leadership.
Environment: The proposed training and research activities will be facilitated by existing strong
international collaborations, resources, infrastructure, and academically rigorous environments of the
UW Schools of Medicine and Public Health and the Makerere University Lung Institute and College of
Computing & Information Science. Research: Acute lower respiratory illnesses (ALRI) are a leading
cause of childhood mortality in children under 5 years, despite effective prevention and treatment
strategies. The majority of deaths occur in sub-Saharan Africa. Major challenges in case management
exist in low- and middle-income countries (LMICs), including poor adherence to ALRI guidelines, lack
of health worker training, and lack of decision support to recognize wheezing illnesses (asthma and
bronchiolitis), which represent up to 50% of ALRI in children. Acute Lower Respiratory Illness Treatment
Evaluation (ALRITE) is a comprehensive guideline- and evidence-based ALRI clinical decision support
mobile health tool Dr. Ellington developed with her team. ALRITE has demonstrated preliminary
acceptability and usability in Ugandan health centers but requires optimization for health system
integration and pilot-testing in clinical care. Dr. Ellington proposes a feasibility study in 4 Ugandan
health centers to 1) identify promising implementation strategies for the ALRITE intervention to optimize
implementation, 2) pilot-test study feasibility of the ALRITE tool and its effectiveness for diagnosis and
management of wheezing illness and pneumonia in children 1-59 months using an interrupted time
series design, and 3) assess the outcomes of implementation following ALRITE deployment and
barriers/facilitators of ALRITE use. Successful completion of these aims will improve implementation of
decision support tools in Uganda and other LMICs, provide critical preliminary data to support Dr.
Ellington’s planned R01 for a cluster RCT evaluating clinical effectiveness of the ALRITE intervention
in LMICs, and provide Dr. Ellington with the training and experience needed to transition to research
independence.

Public health relevance
PROJECT NARRATIVE This project will help address one of the leading causes of mortality in young children worldwide, acute lower respiratory illnesses (ALRI), through a mobile health decision support tool called ALRITE. ALRITE is designed as a point-of-care decision support tool to aid health workers in diagnosing and treating young children with ALRI in Uganda. The proposed study is a critical step towards the ultimate goal of improving outcomes for pediatric ALRI in resource-constrained settings.